Genomics

The Genomics Shared Resource (GSR) provides a broad spectrum of services and resources designed to
make the state-of-the-art techniques used in DNA sequence and transcript analysis readily available to the
Holden Comprehensive Cancer Center (HCCC) laboratory and clinical research communities. The research based services and resources of the GSR include: 1) DNA sequencing, including whole exome sequencing, 2)
custom oligonucleotides, 3) DNA microarrays (Illumina BeadArray system), 4) real-time PCR, 5) molecular
biology computing, and 6) genome, mRNA and single cell sequencing using next-generation sequencing
(NGS) technologies. The GSR also provides access to state-of-the-art informatics including bioinformatics
software and tools, public/local data and databases and computing and machine-learning/artificial intelligence
capabilities. Molecular biology computing personnel work closely with investigators early in the process to
improve study design and assure generation of high-quality data that meets the needs of the investigators.
GSR also continues to evaluate and update services to remain cutting-edge and provide new services needed
and serves HCCC investigators from each of the HCCC programs.

Public health relevance
PROJECT NARRATIVE Not applicable